Portable Nanostructured Photonic Crystal Device for HIV-1 Viral Load

? DESCRIPTION (provided by applicant: The HIV/AIDS pandemic has had a devastating global impact causing more than 30 million HIV-1 infections and over 25 million deaths worldwide. In addition, it is estimated that annually over 450,000 infants are infected through mother-to-child transmission (MTCT). Although antiretroviral therapy (ART) is effective to save lives and reduce MTCT, the coverage of ART in treatment-eligible patients in developing countries is only approximately 67% due to the lack of simple, inexpensive and rapid near-patient treatment monitoring tools. To address the unmet need, we propose to develop an HIV-1 viral load monitoring microfluidic platform technology development of a sensitive photonic crystal sensing technology. This technology detects and quantifies the binding of biotargets (e.g., HIV-1 virus particles) to an optical sensing surface due to the change of bulk index of refraction. The resulted shift in the peak wavelength value correlates with the concentration of biotargets in a biological sample. This technology- driven proposal addresses a significant global clinical need and aims to deliver a portable photonic crystal device that can (i) selectively capture HIV-1 from whole blood, (ii) be sensitive within the clinical cut-off (with ±10% error range), inexpensive (<$1), rapid (within 30 minutes), and (iii) handle fingerprick whole blood (up to 100 µL) to aid i HIV patient care and treatment in resource-constrained settings. The delivery of this photonic crystal-based HIV-1 viral load monitoring microchips can significantly facilitate the expansion of ART in developing countries, achieving universal access to ART to control the AIDS pandemic.

Public health relevance
PUBLIC HEALTH RELEVANCE: Despite tremendous efforts made to control the HIV/AIDS pandemic, the lack of simple, inexpensive and rapid HIV-1 viral load monitoring tools significantly prevent universal access to antiretroviral therapy (ART) in developing countries. We aim to develop nanostructured photonic crystal devices to measure HIV-1 viral load from unprocessed whole blood samples to guide ART in resource-limited settings without requiring conventional, central laboratory-based HIV-1 RNA nucleic acid amplification technologies. This sensitive nanotechnology enabled microchip can facilitate the global expansion of ART, especially in developing countries, to save lives and reduce transmission.